IGF::OT::IGF::C101451 - A-E SERVICES FOR DEVELOPMENT OF PROGRAM OF REQUIREMENTS (POR) FOR 5635 FISHERS LANE - NIH ROCKVILLE, MD SITEMODIFICATION 0001 - ADDITIONAL SERVICES TO INCLUDE AN INSTITUTE AN

abstract: